A Novel Bispecific Antibody for the Treatment of Idiopathic Pulmonary Fibrosis

Project Summary
Our objective is to produce a bispecific antibody, VTC-890, capable of binding two proinflammatory cytokines,
LIGHT (TNFSF14) and TL1A (TNFSF15), for the treatment of Idiopathic Pulmonary Fibrosis (IPF). IPF is a
chronic fibrotic lung disease characterized by widespread progressive scarring of the lungs. Patients with IPF
show declining lung function leading to early death 5, 47.We will demonstrate that VTC-890 can effectively block
the receptor binding domains of LIGHT and TL1A, thereby reducing downstream activation of pro-fibrotic
pathways that lead to tissue remodeling in IPF.
The causes of IPF are complex and include genetics and environmental exposure, but the involvement of
cytokine-dependent processes is demonstrated by the recent introduction of two new antifibrotic, anti-
inflammatory medications that slow the rate of respiratory decline. Unfortunately, therapeutic benefits are
relatively minor and IPF is still invariably fatal, typically in about 3.5 years. No present treatment stops or
reverses the progression of the disease, and patients sometimes discontinue treatment with the therapeutics
due to side effects5.
Important characteristic features of the progression of IPF are tissue remodeling and fibrosis22. In this regard,
our team published the first reports that a genetic deficiency in the TNF superfamily cytokine LIGHT and
blocking LIGHT binding to its receptors (HVEM/TNFRSF14 and LTβR/TNFRSF14), strongly reduced lung
tissue remodeling and fibrosis in animal models. We also showed that injection of recombinant LIGHT protein
into the lungs promoted the tissue remodeling characteristic of IPF13, 14. In our recent published studies15, we
have now show that TL1A also strongly contributes to tissue remodeling in these same models, and injection of
recombinant TL1A into the lungs of mice drives pathology independent of LIGHT, suggesting it plays a
complementary and synergistic role to LIGHT in tissue remodeling15.
This proposal is designed to produce and validate a novel bispecific antibody, VTC-890, capable of blocking
the receptor binding of both LIGHT and TL1A for the treatment of IPF. The high-level objectives are to: 1)
establish VTC-890 production and analytical assays to support manufacturing, purification, bioactivity
determination, and formulation; 2) complete the animal studies required to support our clinical study design;
and 3) identify the remaining preclinical datasets necessary to obtain FDA IND approval. Successful
commercialization of VTC-890 would ultimately provide a profound front-line therapy for the treatment of IPF
and potentially other fibrotic diseases, such as systemic sclerosis and asthma.

Public health relevance
Project Narrative Idiopathic Pulmonary Fibrosis (IPF) is a chronic pulmonary disease characterized by vascular injury and progressive fibrosis of the lungs. This project aims to develop a bispecific antibody, VTC-890, for the treatment of IPF. Since present therapies for IPF fail to prevent death or improve quality of life for patients, successful commercialization of VTC-890 would ultimately provide profound relief for an incurable, fatal disease.